Training Program in Vision Science

Project Summary
Thirty-two Vision Science preceptors, members of the Vision Science Graduate Group
from 7 different departments/11 programs on the U.C. Berkeley campus (optometry and
vision science, psychology, molecular and cell biology, neurobiology, neuroscience,
infectious disease and immunology, bioengineering, computer science, physics,
electrical engineering, chemical and biomolecular engineering), seek support for 10
predoctoral trainees and 1 postdoctoral trainee. Support is sought for 2 years of
graduate training toward the PhD for the predoctoral trainees and for 3 years for the
health-profession degree seeking trainee (OD, MD etc.)
The interdisciplinary program in Vision Science has been in existence for over 80 years.
The first PhD graduated in 1950. There are currently 1 postdoctoral (OD) and 32
predoctoral students engaged in studies leading to the PhD in Vision Science. In
addition, there are 30 post-doctoral fellows currently training in the laboratories of the
faculty of the Vision Science Graduate Group. Of the 284 trainees who have received
research degree training in Vision Science (almost all PhD), the majority are now active
vision researchers. Many have successfully competed for independent research funding.
Our purpose is to attract outstanding trainees who will develop independent and
productive vision research careers.
Pre-doctoral and health profession degree trainees, most with additional formal basic
science training (e.g., cell biology, immunology, neurobiology, epidemiology, or
biostatistics), will earn Ph.D. (Vision Science) degrees. Each predoctoral trainee will
receive stipend support during the first two years from the NIH Training Grant,
supplemented by the Departmental and University fellowships. During the final three
years, support will be provided entirely from resources of the University of California
(primarily through individual faculty research grants). Health profession trainees will be
supported for the first three years followed by other funding. Trainees will complete the
formal course and teaching requirements and will be trained in laboratory research
techniques in both basic sciences and vision science. The training is augmented by the
extensive resources of the Berkeley campus and the technical support provided to the
Vision Science Graduate Group and the NEI Core Grant.

Public health relevance
Project Narrative The Vision Science Graduate Group on the UC Berkeley campus is engaged in training predoctoral and postdoctoral trainees from a broad range of backgrounds to generate new knowledge about the eye and visual system in health and disease - from the basic mechanisms of vision through translation and application of new therapies to people with vision disorders.